Endoplasmic Reticulum Stress and Alcohol Neurotoxicity

Children who experience prenatal alcohol exposure may develop Fetal Alcohol Spectrum Disorders (FASD)
and the central nervous system (CNS) is particularly susceptible to alcohol-induced damage. Children of FASD
have significant neurobehavioral deficits. FASD is diagnosed at an alarmingly high rate making it the most
common non-heritable cause of mental disability and resulting in tremendous personal and societal costs. It is
therefore important to understand mechanisms that contribute to these adverse effects and find ways to improve
outcomes in these individuals. The neurobehavioral deficits observed in FASD results from structural damages
in the brain. It has been well-established that there is a temporal and spatial vulnerability to alcohol-induced
neuronal damage during the development. That is, neurons at the different developmental stage display
differential sensitivity to alcohol-induced damage. Even at the same developmental stage, neurons in different
structures are differentially impacted by alcohol exposure. However, the underlying mechanisms are unclear.
The endoplasmic reticulum (ER) is an important organelle involved in protein quality control. The accumulation
of improperly folded proteins within the ER lumen results in ER stress, and sustained ER stress causes cell
death. Neuronal cells are particularly sensitive to ER stress. Recently it is shown that ER stress plays an
important and more specific role in alcohol-induced CNS damage. The ability of immature neurons to maintain
ER homeostasis develops gradually and heterogeneously. We hypothesize that the temporal and spatial
vulnerability of developing brain to alcohol-induced neuronal damage is mediated by the sensitivity to ER stress.
That is, the differential sensitivity of neurons to alcohol neurotoxicity during the development is due to the
difference of neuronal ability to maintain ER homeostasis and mitigate ER stress. We further hypothesize that
enhancing neuronal ability to maintain ER homeostasis will make immature neurons resistant to alcohol-induced
neurodegeneration and improve neurobehavioral deficits. We propose three specific aims to test these
hypotheses. Specific Aim 1 will determine whether the temporal and spatial vulnerability to alcohol-induced
neuronal damage is mediated by the sensitivity to ER stress in the developing brain. Specific Aim 2 will determine
whether enhancing neuronal ability to maintain ER homeostasis can protect immature neurons against alcohol-
induced ER stress and neurodegeneration in the developing brain. Specific Aim 3 will determine whether
enhancing neuronal ability to maintain neuronal ER homeostasis can improve alcohol-induced neurobehavioral
deficits. This proposal will use both in vitro and in vivo approaches to investigate how ER stress contributes to
neuronal vulnerability to alcohol. It will employ genetic manipulations and chemical intervention by FDA-approved
drugs to mitigate ER stress in immature neurons. The cohesive specific aims will not only elucidate the cellular
and molecular mechanisms underlying the temporal and spatial vulnerability to alcohol, but also open a novel
avenue for the intervention/therapy of FASD.

Public health relevance
Alcohol consumption during pregnancy causes Fetal Alcohol Spectrum Disorders (FASD). Disruption of endoplasmic reticulum (ER) homeostasis may contribute to alcohol-induced damage to the developing brain. The study will explore the underlying mechanisms and develop a new therapeutic approach.